Flexible Control Authority With a Robotic Arm: Facilitating Seamless Transitions Between User and Robot Control in Multi-Action Manipulation Tasks.

This proposal discusses the development and evaluation of a collaborative Assistive Robotic Manipulator
(ARM) which allows the Veteran to preference control authority (user moving the arm versus robot software
moving the arm) at any point in a multi-action task: flexible control authority (FlexCA). Veterans with
tetraplegia, amyotrophic lateral sclerosis (ALS), and multiple sclerosis (MS) can readily access electric power
wheelchairs (EPWs) for their mobility needs but are still limited in performing manipulation tasks. Current
options for manipulation assistance include low tech specialized manipulation tools, modifications of the
environment, caregiver support, and robotic arms. ARMs for EPW users are capable of a variety of functions
but are unintuitive to control. Manually driving the control input for an ARM requires reasoning about many
different modes for moving the arm in three directions, rotating the arm’s wrist in three directions, and opening
and closing the gripper. The addition of more intelligent robot software assistance can ease control burdens
but should also adapt to a user’s changing abilities, preferences, and contexts. Previous work pre-assigns
control authority, which creates a rigid order of actions that causes unexpected behavior if the user decides to
interrupt the system. This career development award (CDA-1) addresses an unforeseen challenge, the ability
to allow the user to change their control authority preference by creating a seamless transition between manual
control and robot autonomous operation both within and between different functional task actions. This is
achieved through a development aim and an evaluation aim. The first aim is to develop the FlexCA assistive
dialogue control system for ARMs that tracks the user state within a kitchen task allowing the Veteran to initiate
control authority. The first goal of this aim is to infer the current state within a multi-action task regardless of
how the robot is controlled. This is formulated as a sequential stochastic state model that leverages
environment observations and user input to successfully monitor and estimate the state allowing the robotic
software to seamlessly pick up wherever the user leaves off. Input and feedback from the system is initiated
through the development of a voice-activated user interface. The system is evaluated in two phases. The first
phase involves a representative user that actively participates in the iterative design process, and a group of
benchmark users. The second phase evaluates the FlexCA system among Veterans with limited arm function
who use EPWs. Veterans are recruited to provide objective performance measures and subjective
assessments of usability and task workload. This work empowers Veterans with upper limb impairment to
perform realistic functional tasks with an ARM. By achieving our aims, algorithmic developments can be
generalized towards other assistive devices, and inform future models for more appropriately matching
assistive systems that adapt to the user positively impacting their quality of life.
This CDA-1 provides training experience in assistive technology, clinical methodology, and human
robot interaction that bridges the candidate’s previous experience in robotics and software industry with the
development of assistive technology to increase Veteran independence. Immediate goals include constructing
user-centric driven technology specific to rehabilitation robotics and assistive devices and understanding the
methodology of human subject study design. Long-term career goals include future work as a principal
investigator on topics that merge probabilistic techniques, such as predictive modeling and stochastic decision
making, for more context-aware and user-centric assistive technology platforms that include smart home
environments, robotic wheelchairs, and robotic assistive arms.

Public health relevance
A significant portion of individuals with upper limb impairments are military service members or Veterans. In a survey of 347 people with tetraplegia, regaining arm and hand function was chosen most important for improving their quality of life. The VA’s commitment to early investment in innovation can improve the quality of life of Veterans with upper limb impairment and pave the way for more ubiquitous use of ARMs in the military, Veteran, and civilian population. The VA has also recognized the importance of caregiver input through their Campaign for Inclusive Care. Since most military caregivers are family members, it is even more important for technology to optimize their caregiver role. A collaborative flexible ARM shared control system that allows the Veteran to dictate how its usage best meets their changing needs will increase Veteran’s ability to engage in self-care, allow for greater participation in the community, and allow for those who care for Veterans with disabilities to spend more time in the role of family member, further positively impacting quality of life.